Mayo Clinic Hepatobiliary SPORE

OVERALL – PROJECT SUMMARY
This is a renewal of the NCI-supported Mayo Clinic SPORE in Hepatobiliary Cancers (HBC), with a foundation built upon innovative translational science and utilizing state-of-the-art approaches to understand and treat liver cancers; these are the second leading cause of cancer deaths in the country. The breadth of the projects spans hepatocellular carcinoma (HCC), cholangiocarcinoma (CCA), and pediatric/young adult fibrolamellar (FLC). Three unique translational projects promise significant steps forward, supported by three well-constructed and responsive cores. Additionally, robust Developmental Research and Career Enhancement Programs continue to identify and support talented HBC-investigators Ongoing support from the Mayo Foundation and Mayo Clinic Comprehensive Cancer Center benefit these components by enabling integrated resources, skilled staff, and leadership guidance to ensure success. The approach remains comprehensive, milestone focused, and patient centered. For example, the completion of former Project 3 has led to a novel first-in- class compound that has advanced to clinical trial. Three projects have developed successfully into innovative renewal pro- jects that utilize novel approaches of immunotherapeutics, computational biology, and chemical genomics. The translational projects in this renewal proposal investigate HBC biology to enhance therapeutic response, building on recent, promising clinical and preclinical advances, summarized below. Diagnostics and drug repurposing for FLC: Project 1 demonstrates 1) differential therapeutic sensitivity of FLC but with 2) variability in patient responsiveness, and now extends into a novel functional approach to precision medicine by 3) defining therapeutics that affect FLC cell viability, while also 4) developing blood- and urine-based biomarkers for tumor burden. Targeting yes- associated protein (YAP), transcriptional enhanced associate domain (TEAD) oncogenic signaling, and therapeutic resistance in CCA: developed from studies defining alternative mechanisms activating this “undruggable” target (YAP) in CCA, Project 2 will 1) leverage a novel inhibitor in preclinical models and 2) test clinical efficacy in a clinical trial. Reversal of the immune suppressive HCC microenvironment through appropriately timed and optimally delivered combination viroimmunotherapies: advancing the use of oncolytic viruses to augment the killing of tumor cells for HCC, new Project 3 now will 1) test the clinical efficacy of a novel virotherapy combined with standard of care immunotherapy, 2) develop new combination viroimmunotherapies with increased potency in pre-clinical Sleeping Beauty models, and 3) develop a novel standard of care, virotherapy, CAR T-cell therapy combination. Collectively, this innovative, interactive, and highly collaborative translational research program is expected to advance prevention, early detection, diagnosis, treatment, and prognosis of patients with cancers of the liver and biliary tree.

Public health relevance
OVERALL – PROJECT NARRATIVE The Mayo Clinic Specialized Programs of Research Excellence in Hepatobiliary Cancers, funded by the National Cancer Institute, has developed new tools to improve early detection, diagnosis, and therapeutic treatment for patients facing these deadly liver and biliary malignancies. Each of the three projects and shared resources cores focuses on improving the duration and quality of life for these patients by markedly expanding scientific knowledge, systematic tools, and clinical practice of hepatobiliary cancer medicine.